miRNA Expression Patterns of Neuron Originating Exosomes and Postpartum Depression

Project Summary
Postpartum depression (PPD) significantly affects many new mothers, leading to increased mortality and
impairing their ability to care for their newborns and their overall well-being. The underlying neurobiological
mechanisms of PPD remain unclear, partly due to research limitations focusing on peripheral samples that do
not adequately reveal central nervous system (CNS) processes. One promising alternative approach is
analyzing the cargo of neuron-derived exosomes (NDEs), which are small, membrane-bound sacs transporting
various cargo like proteins, nucleic acids, and lipids throughout the body. The small size of the exosomes
allows them to easily pass through the blood-brain barrier. These exosomes, released as part of normal cell
physiology, are found in various biofluids like blood serum and contain microRNA (miRNA) as one it primary
cargo, which is critical for gene expression regulation. There is substantial evidence linking NDEs in peripheral
blood to CNS pathology. For example, NDEs from Alzheimer’s and Parkinson’s patients carry disease-specific
proteins, suggesting that their cargo reflects brain pathologies. Studies using rodent models and CNS neuron
tracking have confirmed that these exosomes can cross the blood-brain barrier and appear in peripheral blood,
further supporting their potential as indicators of brain biology. This research proposal aims to investigate
the relationship between PPD and miRNA expression patterns of neuron-derived exosomes. We
hypothesize that changes in brain-originating exosome miRNA may reflect alterations in neural pathways
linked to PPD. To achieve study aims, we will leverage existing serum samples from a longitudinal study of
adult pregnant women. Our study will consist of three groups of women including 25 women with postpartum
onset of a major depressive episode (PPD), 25 women with non-pregnancy related major depression disorder
(MDD), and 25 women without a history of PPD or MDD (controls). All women were measured across the first,
second, and third trimester as well as the postpartum period, for a total of 300 person-time points. Our two aims
will 1) characterize miRNA patterns across pregnancy and into the postpartum and 2) compare perinatal NDE
miRNA patterns between mood disorder groups and controls. NDE miRNAs identified in study aims will be
probed with complementary network-based analyses to identify involved neurobiological pathways. Insights
from this study will clarify whether there is scientific merit to proceed to in vivo studies as well as causally
informative, longitudinal studies of PPD. This approach promises not only to enhance our understanding of
PPD but also to provide broader insights into maternal mental health and the biological basis of this condition.

Public health relevance
Project Narrative Postpartum depression (PPD) significantly affects mothers, impacting their wellbeing and their ability to care for their newborns. This study proposes to explore the link between PPD and variations in the microRNA content of neuron-derived exosomes, which play a crucial role in intercellular communication and gene regulation. By analyzing existing samples and data from a large group of women during pregnancy and the postpartum, this proposal seeks to provide new insights into the neurobiological processes underlying PPD by monitoring brain activity through changes in exosomes originating in the brain.